Targeting Hypervigilance and Autonomic Arousal: the Psycho-physiologic Model of GERD

PROJECT SUMMARY
GERD affects roughly 20% of the U.S. population and the direct and indirect costs of GERD are substantial,
totaling close to 50 billion dollars per year. Evidence supports that a large proportion of this cost and poor
clinical outcomes in GERD are related to poor healthcare decisions by both the physician and the patient. The
problem of inappropriate GERD management stems from three main issues. First, the disease is heterogeneous
and requires treatment informed by a precision model. Second, the current paradigm largely ignores the
important brain-gut interactions that drive symptoms and healthcare utilization. Third, there is a paucity of well-
performed comparative effectiveness trials focused on assessing treatments beyond acid suppression. The
overarching goal of this project over the first two funding cycles primarily focused on the first two problems and
we have made major progress developing new physiological predictors of outcome and a more efficient process
of phenotyping patients. During the first two cycles, we also determined that psychological distress, in the form
of hypervigilance and autonomic arousal, is a major component of patient outcome in GERD. We were able to
refute dogma suggesting that there is an inverse relationship between psychological distress and organic
disease. Instead, our data proved that hypervigilance was as important as the physiologic perturbations in
determining symptom severity and quality of life and these factors were important across the entire spectrum of
disease presentation. This work led to the creation of the Psycho-Physiologic Model of GERD that focuses on
targeting the primary physiologic abnormality and the important brain-gut interactions driving disease severity.
The current competitive renewal will focus on the third problem by performing much needed randomized
controlled trials evaluating the effectiveness of behavioral interventions in patients with functional heartburn and
refractory GERD. We will use physiomarkers defined during the previous funding cycle to phenotype the patients
and use cognitive behavioral interventions to modulate hypervigilance to test the Psycho-Physiologic Model of
GERD. Cognitive Behavioral Therapy (CBT) is able to improve hypervigilance and symptom specific autonomic
arousal and thus, we will test our theory that CBT can improve outcomes in GERD by targeting these two
important psychologic stressors. We will also continue our focus on the interplay of psychology and physiology
by determining whether increased mucosal permeability is associated with reflux perception and whether this is
modified by hypervigilance and autonomic disruption. This proposal will have a dramatic impact on the field as
it will provide important clinical data to guide behavioral treatments in gastroenterology and further define how
brain-gut interactions influence symptoms and quality of life in GERD.

Public health relevance
PROJECT NARRATIVE Although gastroesophageal reflux disease (GERD) is a common medical condition affecting at least 10-20% of the adult US population, it is poorly understood in terms of the mechanisms causing reflux and how symptoms are triggered by reflux. This proposal will attempt to develop a better understanding of the complex interaction of the brain-gut connection in promoting reflux symptoms by performing clinical trials using behavioral therapies to improve symptoms in GERD. This project will also enable us to develop a better understanding of how psychological distress can impact gastrointestinal diseases as we will study how changes in stress affect symptoms in patients with the same physiology.